Recruitment Core

Recruitment Core: Abstract
We propose establishing a Recruitment Core (RC) within the Center for Health Disparities
Research at UCR (HDR@UCR), which will build on recent success at UCR, an established
minority-serving institution, in recruiting and hiring a diverse senior faculty cohort of researchers.
The primary goal of the RC will be to recruit and retain previously funded NIH researchers who
can support the Investigator Development Core and Research Infrastructure Core, as well as
serve as mentors for research fellows participating in the HDR@UCR. Our goal will be achieved
by developing a strong pool of potential candidates through networks with existing institutions
whose mission is to support underrepresented NIH researchers. The networks and consequent
recruitment pool will lead to at least two faculty hires. Finally, in collaboration with the
Investigator Development Core and Research Infrastructure Core, we will develop a strategy to
retain these new and existing faculty.